Probing spatiotemporal mechanobiology through novel dynamic material platforms

PROJECT SUMMARY
The long-term goal of the Corbin lab is to study emergent time-dependent cellular responses through reimagining
engineered microdevices. Cells engage in a continuous and dynamic interplay with their surroundings, and
respond rapidly and with remarkable precision to variations in their mechanical environment including
topography, stiffness, and stretching. There is a critical need to make an in-vitro system that sufficiently reflects
the essential adaptive and maladaptive processes and phenotypic benchmarks to understand the vital link
between biomechanics and cell structure and function. Materials with the ability to change mechanical properties
have the potential to reshape our understanding of how cells interact with their micro-environments. Broadly, we
seek to address two major challenges of dynamic engineering materials for mechanobiology interrogation: 1)
tailoring effective and spatio-temporal realistic biomechanical cues to drive desirable interactions and responses
and 2) manipulating and modeling the complex network of many signals operating on various lengths and
timescales that determine cell fate. The Corbin lab has focused on developing a unifying engineered materials
platform to deconstruct and decode how biological behavior can arise from a wide range of dynamic
biomechanical stimuli. Major advances to date have included: (1) the evaluation of magnetorheological
elastomers as a novel tunable and reversible biomechanics tool to study cardiomyocyte mechanosensitivity, (2)
the discovery of pathologic mechanical increment induces rapid remodeling of cardiomyocytes, (3) the creation
of local spatial mechanics and topographic mechanics with the same platform, and (4) quantify the directionality
and magnitude of how spatial mechanics and chemical applications interfere or synergize with each other in time
– in other terms how they “compete” or “cooperate.” In this proposal, we will dramatically enhance our efforts to
engineer the elements of biological interaction with the dynamic mechanical microenvironment. We will expand
our platform to include simultaneous control of stiffness gradients and adhesion gradients, local stimulation of
substrate stiffness to examine the spread of mechanotransductive signaling, and cyclic variations in stiffness to
mimic periodic biomechanical events. These future efforts are well suited to the research program, given the
widely applicable framework to address the broader definition of invisible forces that intrinsically link cells and
biomechanics.

Public health relevance
NARRATIVE Materials with the ability to change mechanical properties have the potential to reshape our understanding of how cells interact with their micro-environments. With this work, we aim to engineer a spatiotemporal dynamically responsive microenvironment optimized to allow us to identify the cascade of mechanical stimuli transducing signals by spatially and temporally manipulating the mechanical environment.